Mechanisms of DSCAM-mediated self-avoidance

PROJECT SUMMARY/ABSTRACT
Down syndrome cell adhesion molecule (DSCAM) is a member of the Ig superfamily of adhesion molecules
associated with Down syndrome and autism spectrum disorder (ASD). In the mouse retina, DSCAM is
responsible for neuronal self-avoidance at the cell type level; in Dscam-null retinas neurons lose their normal
spacing as they form clusters with other cells of the same subtype (homotypic) and their dendrites fasciculate
with each other. This is unusual, as DSCAM (like most homophilic adhesion molecules) drives adhesion and
cell clustering when expressed in heterologous cell lines. Previous work from the PI found that DSCAM
“masked” adhesion mediated by members of the cadherin superfamily and that masking in different cell
subtypes had a differential dependence on DSCAM’s PDZ-interacting C-terminus. The molecular mechanisms
of this masking remain unknown. Here we propose experiments to define these molecular mechanisms. We
hypothesize that DSCAM masks diverse cell adhesion molecules (CAMs), not only cadherin adhesion, and that
the differential dependence on C-terminal interactions reflect different cell type specific adhesion systems. In
Specific Aim 1 we will use an in vitro assay of adhesive masking to test candidate signaling pathways and
cellular processes. This assay takes advantage of homophilic interactions between CAMs in a neuron and on a
bead, which results in clustering of the neuronal CAM around the bead. Homophilic DSCAM interactions
prevent the clustering of other CAMs (e.g., cadherins). We will use a variety of pharmacological and genetic
manipulations to test candidate mechanisms in this assay, and we will verify findings with in vivo
electroporation. In Specific Aim 2, we will test our hypothesis that differential clustering and fasciculation in C-
terminal mutants reflects different sets of cell-type-specific CAMs, and DSCAM’s PDZ-interacting motif is only
required to mask a subset of CAMs. To do this, we will leverage new datasets describing cell type specific
gene expression to identify candidate CAMs expressed in cell types that either require DSCAMs C-terminal
PDZ interactions for normal spacing or do not require DSCAM’s C-terminus. Using in vivo electroporation into
retina-specific conditional loss of function mutants and into C-terminal truncation mutants, we will test if these
CAMs require DSCAM’s C-terminus for masking. In Specific Aim 3, we will test ASD-associated DSCAM
mutations in the neuron/bead assay by rescuing masking in Dscam-deficient neurons. Cell adhesion has
emerged as a major theme in ASD pathology and DSCAM is positioned as a key regulator of this process. The
completion of these studies will provide crucial first steps towards understanding how DSCAM dynamically
regulates adhesive systems during development to prevent excessive adhesion while allowing appropriate
CAM interactions, addressing fundamental questions in retinal neural development with implications in
neurodevelopmental disorders like ASD.

Public health relevance
PROJECT NARRATIVE The proposed research will address the biology of neural circuit formation in the retina and is relevant to public health for understanding both the biology of vision and the basic processes through which the nervous system organizes itself during development. Further, mutations in the gene on which we focus have been found in autism spectrum disorder, and learning how these basic processes function will shed light on the pathology of this and related disorders.